RELATIONSHIP BETWEEN INSULIN RESISTANCE AND EARLY DEVELOPMENT OF ATHEROGENESIS

The central focus of this research protocol is on the importance of insulin resistance to insulin mediated glucose uptake and the compensatory hyperinsulinemia in modulation of metabolic changes that increase a risk for coronary heart disease. Our specific aims are to establish a link between insulin resistance and the cluster of metabolic abnormalities associated with this defect in insulin action such as hypertension and endothelium-dependent vasodilatation, endothelium-dependent vascular reactivity, EDVR, and determinants of endothelial-monocyte interaction. Also to evaluate the metabolic changes associated with insulin resistance and dietary manipulation in order to exaggerate their associated deleterious effects on endothelial dysfunction and monocyte-endothelial interaction and lipid metabolism.